Technical and Administrative Management Services in Support of Domestic and International Collaborative Research Efforts

This funding supports core clinical research infrastructure to facilitate multicenter, randomized, controlled clinical trials on the Ebola virus and other infectious diseases in Liberia.